Sphingolipid Animal Cancer Pathobiology Core

ABSTRACT
The overall objective of the Sphingolipid Animal Cancer Pathobiology (SACP) Shared Resource (SR) is
to provide the Project Investigators with the knowledge, resources, and ability to fully and efficiently utilize animal
models in the execution of their research projects and to advance their preclinical studies. Through the SACP-
SR, the different projects utilize genetically engineered mouse models (GEMMs) for the investigation of the
mechanisms involved in carcinogenesis, metastasis, tumor microenvironment and chemotherapeutic responses,
specifically utilizing a unique set of animals with deletions in genes of sphingolipid metabolism coupled with
pathologically relevant animal models of specific cancers. Indeed, the SACP has become a national repository
for sphingolipid knock out mice, having generated several of them.
Preclinical models, specifically animal models, of cancer are invaluable tools for the identification and
validation of novel functions, interventions, therapeutic targets, and biomarkers. Therefore, the Core will provide
the projects with “start-to-finish” expertise in utilizing in vivo models in their research projects. The SACP has
already generated several sphingolipid knockout mice (both, total body and tissue specific) that in combination
with pathologically relevant animal models of specific cancer has become in a key resource for the test of different
hypothesis. The Core will assist with i) animal model selection; ii) generation of animal models of carcinogenesis,
including the generation of novel GEMMs; iii) development and use of patient-derived xenografts (PDXs) and
engraftment of human cells in vivo; iv) collection and preparation of tissue samples for in situ analysis of
sphingolipids using MALDI; v) Biobanking of samples for future and/or collaborative studies; and vi) access, use
and coordination with other critical relevant shared resources available through the Cancer Center and/or
University. To this end the SACP Core has 3 Specific Aims: Aim 1. Provide investigators with the necessary
resources to implement in vivo models of cancer; Aim 2. Enable the execution of preclinical and translational
models in carcinogenesis, as well as Biobanking of samples; and Aim 3. Advance the impact of in vivo research
using Shared Resources, animal model alternatives, and data management.
The services and expertise of the SACP Core will facilitate in vivo research outlined in this proposal and
will provide the expertise to support the Project Investigators. With the incorporation of carcinogenesis models,
animal models of chemotherapy, and GEMMs in sphingolipids, the SACP Core is evolving as a unique and
enabling Core that is critical for the success of the Program Projects and their advancement to preclinical studies.

Public health relevance
Project narrative The overall objective of the Sphingolipid Animal Cancer Pathobiology (SACP) Shared Resource is to provide the Project leaders of this Program Project with the knowledge, resources and ability to fully and efficiently utilize animal models in the execution of their research projects and to advance their preclinical studies. Through the SACP Core, the projects utilize genetically engineered mouse models (GEMM) for the investigation of the mechanisms involved in carcinogenesis, metastasis and chemotherapeutic response, specifically utilizing a unique set of animals with deletions in genes of sphingolipid metabolism coupled with pathologically relevant animal models of specific cancers. The SACP Core provides investigators with the necessary resources and assistant to utilize animal models in the execution of their in vivo studies in one central location.